Image-Guided Intraductal Ablative Procedure for Primary Prevention of Breast Cancer

PROJECT ABSTRACT
Breast cancer (BC) is the most prevalent cancer and the second-leading cause of cancer-related death for
women in the USA. For moderate-risk and, especially, low-risk women with a 1-in-8 lifelong chance of developing
BC, there are very few options available to reduce their risk. For high-risk women, prophylactic mastectomy is
currently the most effective procedure for preventing BC. This aggressive surgical procedure affects women
physically, emotionally, psychologically, aesthetically, and socially. Therefore, there is a need to develop new
strategies for primary prevention that focus on high-risk women, but that could also be applied to moderate- and
low-risk women. Our overall hypothesis is that the local killing of mammary epithelial cells will be as effective as
prophylactic mastectomy in preventing BC, but with minimal side effects. Our preliminary and published data
demonstrate that intraductal (ID) injection of a 70% ethanol (EtOH) solution is effective at locally ablating
mammary epithelial cells in rodent models and at preventing tumor formation in an aggressive mouse model of
BC. The scientific rigor of prior preclinical and clinical research studies as well as clinical use of ID procedures
strongly support the translational feasibility of our approach. We have developed a refined EtOH-based solution
that contains: tantalum oxide (TaOx) nanoparticles as a high-resolution contrast agent to monitor in vivo filling of
ductal trees by CT/X-ray imaging; and ethyl cellulose as gelling agent to further minimize collateral tissue
damage. The research objectives of this study are: a) to optimize methods for achieving and in vivo visualizing
maximal epithelial ablation; b) to determine the protective benefit and safety concerns of incomplete epithelial
ablation; c) to understand the interactions of the components of the ablative solution with the tissue (e.g., fibrosis)
and their potential interference with imaging findings (e.g., contrast clearance); and d) To apply this knowledge
to establish a clinically compatible procedure for image-guided ablative therapy. To accomplish these, we
propose the following two specific aims: Aim 1) To evaluate therapeutic efficacy and safety profile of the ID
ablative procedure in rat models of breast cancer; Aim 2) To assess scalability of this image-guided ID ablative
procedure in the multi-ductal tree system of a rabbit model. Given the clinical uses of EtOH, diagnostic ID
procedures, and clinically compatible imaging protocols, positive results of this study could rapidly lead to the
evaluation of image-guided EtOH-based ablation procedure in first-in-human clinical trials for high-risk women.
If successful in a high-risk setting, this ID procedure could be offered to moderate- and low-risk women who want
to decrease their chance of developing BC and the cancer-associated anxiety that affects their quality of life.

Public health relevance
PROJECT NARRATIVE This preclinical study will determine the effectiveness of a refined ablative solution at preventing breast tumor formation in cancer-prone rodent models and the scalability of this intraductal procedure to humans by using rabbits as an intermediate and relevant larger animal model. This procedure could lead to a breakthrough in primary prevention of breast cancer by providing a minimally invasive local intervention.